Preventive mechanisms of Age-associated Thrombosis

Summary
Thrombotic events such as myocardial infarction, stroke and deep vein thrombosis are the
leading causes of morbidity and mortality in the elderly. The objective of this proposal is to test
the usefulness of a calorie-restriction (CR) intervention to diminish prothrombotic effects in aged
mice or aged mice with type 2 diabetes and identify a druggable target. Our pioneering studies
have established that increased thrombotic susceptibility in aging is associated with platelet
hyperactivity due to excessive accumulation of oxidants or the reactive oxygen species. We also
observed that the loss in mitochondrial superoxide-dismutase (SOD2) activity within platelets
increases mitochondrial-oxidant burden in aged mice and enhances platelet activation and
susceptibility to arterial thrombosis. Our novel pilot data shows that sirtuin 3 (SIRT3), a
mitochondrial-deacetylase that regulates the activity of several mitochondrial-proteins including
SOD2 is markedly decreased in platelets from aged mice and humans. Consistent with these
observations, in an ongoing clinical study, we observed that increased platelet activation in
healthy older humans and obese-diabetics was overcome by pre-incubation with SIRT3
activator or a SOD2 mimetic, suggesting a Mito-oxidant dependent mechanisms. Recently, we
also reported that the increased potential for venous thrombosis during aging is mediated via
increased total cell-free DNA and this increase is likely due to elevation in mitochondrial DNA.
The damaged circulating mitochondria with cardiolipin surface may also enhance thrombin
generation potential and venous thrombosis. So, a major goal of this proposal is to determine a
role of damaged-mitochondria that mediates age-associated arterial and venous thrombosis and
identify preventive measures. In search for a mitochondria-based protective mechanisms, we
conducted a pilot study and employed a 30% CR in aged mice or aged mice with type 2
diabetes for a month. This 30% CR increased platelet-SIRT3, decreased damage in
mitochondria, decreased platelet activation and lowered thrombotic susceptibility. We
hypothesize that CR protects from age-associated arterial- and venous thrombosis through
distinct mitochondrial mechanisms. We will also test that the presence of insulin resistance or
type two diabetes exacerbates mitochondrial damage and enhances thrombosis which is also
preventable with CR. Aim 1 will focus on platelet SIRT3 activation as a protective mechanism of
CR for arterial thrombosis. Aim 2 will test whether CR prevents from circulating damaged-
mitochondria and mitochondrial-DNA and lowers the susceptibility to venous thrombosis. Thus,
the significance of this proposal is in establishing usefulness of a healthy life-style-intervention
to diminish prothrombotic effects in aging and age-associated comorbidity and identify a
druggable target downstream to CR for translational application.

Public health relevance
Heart attack and stroke due to blood clots in the blood vessels are a primary cause of morbidity/mortality in the older individuals, which is enhanced by risk factors such as diabetes. We will investigate cause of blood clot formation in aged mice and in the mouse with diabetes. We will study if and how calorie restriction protects from age-related blood clot formation.